RENAL FUNCTION/SAFETY/DISPOSITION OF ZOPOLRESTAT IN DIABETES

The aim of this study is to compare the disposition of oral zopolrestat at steady state in subjects with diabetes mellitus and normal renal function to matching subjects with diabetes mellitus and varying degrees of renal insufficiency. 14 Patients completed the study. We sill plan to study 2 additional patients.